EVALUATION OF NEONATAL HPA FUNCTION AFTER CHRONIC STEROID TREATMENT

This is a study which will examine the effect of exogenous glucocorticoids on hypothalamic, pituitary, and adrenal function in neonates treated with steroids. The study will examine steroid treated neonates before, during, and at monthly intervals after steroid treatment for function at each of the levels in the HPA access.